Anopheles FBG: a novel malaria transmission-blocking vaccine target

ABSTRACT
Malaria vaccine RTS,S is a historical milestone to fight malaria. However, we need to continue exploring new
antigens and new approaches to fight against malaria because the protection rate of RTS,S is about 37%. The
difficulty in developing optimal protection of a malaria vaccine indicates the scarcity of suitable malaria vaccine
antigens. Since malaria infection and transmission involve two hosts, malaria transmission through mosquitoes
is obligatory for a Plasmodium parasite to complete its life cycle. The complicated malaria life cycle allows us to
develop a vaccine that targets malaria transmission at the mosquito stage. We identified mosquito
fibrinogen-related protein 1 (FREP1) that facilitates Plasmodium transmission to mosquitoes. FREP1 localizes
in the midgut peritrophic matrix; thus, it is easily accessible by antibodies ingested with blood. Sequence
alignment identified a highly conserved C-terminal fibrinogen-related domain (FBG) among anopheline mosquito
orthologs, and this domain can bind parasites. Notably, antibodies against FBG significantly inhibit the
transmission of multiple Plasmodium species (P. berghei, P. falciparum, and P. vivax) to various species of
Anopheles (An. gambiae and An. dirus). Moreover, monoclonal antibodies against some specific epitopes on
FBG is more active in blocking malaria transmission than polyclonal antibodies, indicating that targeting specific
epitopes on FBG will block malaria transmission more effectively. We have also developed a new molecular
adjuvant that stimulates the strong humoral and cellular immune response. We hypothesize that combining
Anopheles-specific epitopes from FBG and our new molecular adjuvant into one vaccine will trigger a robust
immune response to block malaria transmission. We will identify these specific epitopes that can be used to
efficiently block malaria transmission from FBG and fuse the epitopes with our molecular adjuvant to generate
nanoparticles for vaccination. Our long-term goal is to improve the malaria vaccine protection rate, while our
short-term goal is to develop an efficient malaria transmission-blocking vaccine (TBV).

Public health relevance
NARRATIVE The suboptimal protective rate of RTS’S urges us to exploit novel antigens and approaches to fight against malaria. Since Anopheles FREP1 FBG domain is important for malaria transmission, it is an ideal target for a new malaria transmission-blocking vaccine. We will enhance the malaria transmission-blocking efficacy by linking critical epitopes on FREP1 FBG domain with a novel molecular adjuvant.